Applications of methods in collaborative science

The project with Steve Kleeberger continues related to the possibly role of nuclear and mitochondrial variants in broncho-pulmonary dysplasia, based on a study of preterm infants carried out in Buenos Aires. Work with Ann Marie Jukic (Epidemiology Branch) and Allen Wilcox produced a massively revised chapter on reproductive epidemiology for the new edition of the standard textbook on epidemiological methods. Work with Ann Marie Jukic produced a paper now in revision on CRP levels as a biomarker for stress and possible effects on fecund ability, based on the Time to Conceive study.